SIGNALING IN TASTE CELLS

DESCRIPTION (provided by applicant): Recent findings indicate that taste buds are much more complex than previously held. Mature taste cells display diverse properties and may communicate among themselves. There are suggestions that chemo-sensory detection by taste receptors is followed by a shaping of the sensory signal within the taste bud prior to transmission to the brain, much as occurs in other sensory system. Yet, the significance of cellular heterogeneity and intercellular signals within the taste bud remain to be explained. We will ask the following questions focused on the most prevalent cells in taste buds, the glial-like Type I cells: 1. Do Type I taste cells regulate the ionic environment in taste buds? Spatially buffering K+ is a key function performed by astrocytes in the CNS. Our data suggest that ROMK and certain other apical channels may form such a K+ clearance pathway in taste buds. We will use confocal Ca imaging of taste buds in lingual slices, afferent nerve recordings and behavioral assays to test the effects of K+ accumulation using physiological, pharmacological, and genetic manipulations of ROMK and other regulators of K+ efflux. 2. Do Type I taste cells use GABA as a gliotransmitter to modulate taste signals? Our pilot data suggest that Type I cells are key players in GABAergic circuits in taste buds. We will complete production of a unique transgenic mouse strain in which yellow fluorescent protein (YFP) is expressed only in Type I cells of taste buds. We will then use these and our other transgenic mice to identify the cell-type selective pattern of receptors and confocal Ca2+ imaging to analyze GABA-mediated responses in these cells types, especially with respect to the impact on taste-evoked responses. 3. Do Type I cells arise from local epithelium and what is their lifespan? Cells in taste buds have an estimated average lifespan of 10-14 days. Earlier studies did not confidently resolve taste cell types. We will employ a new technology for birth-dating cells to assess if the different taste cell types have different lifespans and lineages. Through this series of testable hypotheses and powerful new technologies focused on Type I taste bud cells, we will begin to address the larger, and decades-old question: why do chemosensory taste cells form communities (i.e. taste buds)? What signals are processed within taste buds and what role in taste reception does ongoing communication among the cells serve?

Public health relevance
PUBLIC HEALTH RELEVANCE: Taste buds detect nutritive and potentially poisonous materials through the coordinated action of distinct types of cells housed in taste buds throughout the oral cavity. We will investigate how cells located in taste buds, but resembling glia, may influence the sensitivity of taste buds. Because the proteins responsible for regulation are in an accessible location, understanding these mechanisms introduces the possibility of pharmacological manipulation of aversive and appetitive taste sensations. PROJECT NARRATIVE: RELEVANCE Taste buds detect nutritive and potentially poisonous materials through the coordinated action of distinct types of cells housed in taste buds throughout the oral cavity. We will investigate how cells located in taste buds, but resembling glia, may influence the sensitivity of taste buds. Because the proteins responsible for regulation are in an accessible location, understanding these mechanisms introduces the possibility of pharmacological manipulation of aversive and appetitive taste sensations. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Recent findings indicate that taste buds are much more complex than previously held. Mature taste cells display diverse properties and may communicate among themselves. There are suggestions that chemo- sensory detection by taste receptors is followed by a shaping of the sensory signal within the taste bud prior to transmission to the brain, much as occurs in other sensory system. Yet, the specific significance of cellular heterogeneity and intercellular signals within the taste bud remain to be explained. A rational system of classification of taste cell types has only just begun to inform us about the specific roles of the different cells and how information flows through the taste bud. Receptor (Type II) cells have been investigated at length and are the primary sensors for sweet, bitter, and umami tastes. Presynaptic (Type III) cells detect sour and salty stimuli. In contrast, we know very little about the most abundant cells in taste buds, Type I cells. In the next funding period, we hope to correct this shortfall. Type I taste cells appear to display certain glial-like properties. In the CNS, glia are now recognized to encompass an enormous diversity of functions from dynamically shaping synaptic output, to regulating ionic milieu, to serving as neural stem cells. We hypothesize based on our preliminary data that Type I cells perform glial-like functions including (a) regulating the ionic environment, and (b) releasing paracrine transmitters, particularly GABA, onto excitable cells, thereby shaping taste signals. Much as the resurgent interest in CNS glia is revealing their substantial impact on key neuronal functions, we will test if and how Type I cells modulate signals in taste buds. Our overall goal is to understand the role(s) of the most abundant of the taste cells, Type I, and to develop an integrated view of how the taste bud functions - as a whole rather than as individual cells. Our Aims are: Specific Aim 1: Do Type I taste cells regulate the ionic environment in taste buds? During taste stimulation, action potentials in taste cells likely produce elevated [K+]o in the taste bud. Over time, this would dampen the excitability of Receptor and Presynaptic cells unless there is a mechanism to clear K+. Our data suggest that such a mechanism indeed exists. Type I taste cells express an apical K channel, ROMK, that underlies bulk flow of K+ in the kidney. We propose that ROMK does the same for taste buds. We will use single cell expression profiling of Type I cells to identify additional channels and pumps that may work complementarily with ROMK for spatial buffering of K+. We will use confocal Ca imaging of taste buds in lingual slices to test the effects of K+ accumulation using physiological, pharmacological, and genetic manipulations of ROMK and other regulators of K+ efflux. We will record afferent nerve activity with similar manipulations to assess the importance of K+ clearance for maintaining the sensitivity of taste buds. Lastly, we will use brief- access tests of licking behavior to examine effects of pharmacological and genetic ablation of ROMK. Specific Aim 2: Do Type I taste cells use GABA as a gliotransmitter to modulate taste signals? Our pilot data suggest that Type I cells express a rate-limiting enzyme for GABA synthesis, GAD65, while Receptor and Presynaptic cells express GABAA and GABAB receptors. The findings corroborate in part recent studies from other groups and support the importance of understanding how GABA is used in taste signaling. To expedite this aim, we will complete production of a unique transgenic mouse strain in which yellow fluorescent protein (YFP) is expressed only in Type I cells of taste buds. Using single cell expression profiling and immunostaining, we will use these and our other transgenic mice to identify which cells express receptors and plasma membrane transporters for GABA in taste buds. We will use confocal Ca2+ imaging of intact taste buds in slices to analyze GABA-mediated responses with respect to the cells types and receptors. Importantly, we will test whether GABA modulates taste-evoked Ca2+ responses. Specific Aim 3: Do Type I cells arise from local epithelium and what is their lifespan? Cells in taste buds have an estimated average lifespan of 10-14 days. Importantly, earlier studies did not confidently resolve taste cell types, and whether all types have a similar lifespan. We will employ a new, technology for birth-dating cells, 5-ethynyl-2′-deoxyuridine (EdU) labeling, and evaluate the longevity of Type I and other mature taste cells. Our preliminary data suggest that the different cell types indeed have different lifespans. Further, we will test whether precursors of local keratinizing epithelium gives rise to Type I and other mature taste cell types, or only to a restricted subset of cells. In addition to defining the dynamics and lifespan of taste cells, these studies may help to clarify cellular origins and lineage relationships among all taste cells. Through this series of testable hypotheses and powerful new technologies focused on Type I taste bud cells, we will begin to address the larger, and decades-old question: why do chemosensory taste cells form communities (i.e. taste buds)? What signals are processed within taste buds and what role in taste reception does ongoing communication among the cells serve?